MDMA Neurotoxicity in Nonhuman Primates

DESCRIPTION (provided by applicant): (+) 3, 4-methylenedioxvmethamphetamine (MDMA, "Ecstasy") is a potent serotonin (5-HT) neurotoxin in animals, and growing evidence indicates that MDMA also produces 5-HT neurotoxic effects in humans. Although functional sequelae of MDMA neurotoxicity remain largely unknown, a number of investigators have recently documented abnormalities in cognitive function in MDMA users. Until now, the prevailing view has been that MDMA is a highly selective 5-HT neurotoxin and that cognitive deficits in MDMA users are likely to be related to brain 5-HT injury. However, we have recently found that when MDMA is given to nonhuman primates according to a dosing schedule that closely simulates the use of MDMA by many humans, brain dopamine (DA) neurons are also severely affected. This unexpected preliminary finding raises the possibility that some, or all, of the cognitive impairments noted in human MDMA users may be related to DA or combined DA/5-HT deficiency, rather than 5-HT deficiency. It also raises the possibility that the difficulty in documenting cognitive deficits in MDMA-treated monkeys has been related to that fact that, until now, only monkeys treated with regimens of MDMA that produce selective 5-HT lesions have been evaluated. The overall goal of this competing renewal application is to further characterize MDMA-induced DA neurotoxicity in monkeys, and to explore the potential relation between combined DA/5-HT lesions and alterations in cognitive and/or motor function in MDMA-treated primates. The specific aims of the project are: 1) To confirm and extend recent preliminary findings demonstrating that a dosage regimen of MDMA that closely parallels that used by many humans produces severe DA neurotoxic effects in nonhuman primates, in addition to anticipated 5-HT neurotoxic changes; 2) To determine if squirrel monkeys with MDMA-induced 5-HT/DA lesions demonstrate memory deficits analogous to those seen in human MDMA users; and 3) To determine if monkeys treated with a regimen of MDMA that also damages brain DA neurons are at increased risk for developing a Parkinsonian syndrome following administration of the catecholamine synthesis inhibitor, alpha-methyl-para-tyrosine (AMPT). The long-range goal of the proposed studies is to better understand the long-term effects of MDMA on the primate central nervous system (CNS), with the expectation that such knowledge will provide a framework for reliably interpreting, anticipating and, possibly, treating potential deleterious effects of MDMA in humans.